Pilot Projects Program

Pilot Projects Program - Abstract
The Pilot Projects Program (PPP) is an integral component of the COBRE in Oxidants, Redox Balance and
Stress Signaling and supports our mission to drive innovative redox-related basic and translational studies using
the Center’s core resources and technologies. The overall goal of this program is to continue the significant
momentum we have gained from the first two Phases of this COBRE by providing and prioritizing short-term
funding for pilot studies that are designed to address important scientific questions in redox and signaling
disciplines. We have incorporated innovative features of the PPP in this Phase III application, building on
informatics tools and web resources developed and maintained by the South Carolina Clinical & Translational
Institute (SCTR) that serve as CTSA-supported infrastructure, but provide a platform for electronic submission
and review of applications and progress reports. The PPP will continue to provide and prioritize short-term
funding through a competitive program which incorporates open solicitation, peer review and funding in three
grant categories: Discovery: Attracting junior faculty without prior extramural funding to oxidants, redox balance
and stress signaling research; New Direction: Enticing established investigators in other areas of biomedical
research; and Feasibility: Enabling established redox investigators to explore an area that represents a
significant departure from their currently funded work. The ultimate goal of the program is to provide adequate
resources and training for pilot investigators to develop sufficient preliminary data to prepare a competitive
extramural grant application that will directly utilize one or more of the COBRE cores. Our ultimate goal will be
to use these funds to leverage additional funds and ideas that will expand participation and scientific
competitiveness for the Center. Requests for applications will be solicited annually, four months in advance of
the anticipated award date. Decisions related to the awarding of funds will be based on a rigorous and
independent three-phase peer-review process that is modeled on the NIH system. The initial level of review will
involve screening of proposals to verify that applications meet the eligibility criteria. The second will involve a
panel of internal experts whose primary function will be to evaluate the scientific and technical merits of
applications. A third level of review will be performed by the External Advisory Board. Applications will be scored
using the NIH scale and prioritized according to four criteria: 1) Quality of the research (scientific merit,
innovation, and impact); 2) Relevance to the mission of the Center and direct involvement of one or more COBRE
Cores in the research plan; 3) qualifications of the research team to lead the research effort toward securing
extramural funding and 4) stimulation of collaborative efforts with Center members. We plan to fund two new
and/or continuation projects per year at $50,000 or $75,000 each for one to two years of support. We also
envision that the PPP will enable investigators to form cooperative, interdisciplinary projects where sustainable
studies can be turned into programmatic multi-investigator grant applications (e.g. U or P awards – we have
been successful in garnering U awards, see Overall section) that will have a long-term impact on redox and cell
signaling research at MUSC.